Examining a Multicomponent Intervention to Improve HIV Health among Black Men in Southern Ending the HIV Epidemic in the U.S. Jurisdictions

PROJECT SUMMARY/ABSTRACT
Black men who have sex with men (BMSM) in the U.S. continue to experience a vastly inequitable HIV
burden, particularly in Southern Ending the HIV Epidemic in the U.S. (EHE) jurisdictions. To combat this
alarming trend, there is a need for innovative, accessible, and community-developed interventions to promote
HIV health among BMSM in these areas. Given research that daily and multilevel intersectional stigma
contributes to HIV inequities among BMSM, a multicomponent intervention that addresses multilevel barriers to
HIV health and combats intersectional stigma is essential. In collaboration with THRIVE SS, a leading BMSM-
led community-based organization serving BMSM living with HIV in the Atlanta area, we developed
THRIVE365, an evidence-based multicomponent HIV intervention that provides individual-level health
education and motivation, builds social support among BMSM, facilitates access to culturally-affirmative
healthcare, and combats barriers to housing and economic empowerment in line with the Information-
Motivation-Behavioral skills, social capital, and socioecological models of health. Pilot evidence indicates
THRIVE365 is feasible, acceptable, and efficacious in promoting daily antiretroviral treatment (ART) adherence
and reducing daily depressive symptoms, anxiety symptoms, and emotion regulation difficulties among BMSM
living with HIV. THRIVE365 is ready for a full-scale evaluation guided by the RE-AIM framework that includes a
robust examination of its effectiveness for HIV-related behavioral and psychological outcomes, its moderation
effects on intersectional stigma, and its maintenance and reach over time. We will do so with a fully-powered
hybrid type 2 implementation-effectiveness trial using daily diary methods, self-report follow-ups over 6
months, and paradata to examine daily and longer-term intervention engagement, effects, and adaptations.
The overarching aims of this research are to: 1) Test the effectiveness of THRIVE365 in improving daily and
longer-term HIV-related behavioral health (primary outcome: ART adherence) and psychological health (e.g.,
secondary outcomes: lower depressive and anxiety symptoms) in a 6-month waitlist randomized controlled trial
with 350 BMSM living with HIV in the four Atlanta-area EHE jurisdictions; 2) Examine the moderating effect of
THRIVE365 on associations between intersectional stigma and our primary and secondary HIV outcomes; 3)
Evaluate THRIVE365 maintenance and reach at the user-level (e.g., within-user changes in engagement and
daily effects) and setting-level (e.g., intervention adaptations, BMSM community uptake). Together, these
results will establish the effectiveness of THRIVE365, a community-led, multicomponent intervention, for
improving HIV-related behavioral and psychological health among BMSM living with HIV in four of the EHE
jurisdictions with the greatest HIV burden. THRIVE365 was designed for implementation and is poised to offer
a model for effective HIV care among BMSM in high-stigma, low-resource areas of the U.S. South and beyond.

Public health relevance
PROJECT NARRATIVE Given the overwhelming burden of HIV among Black men who have sex with men (BMSM) in Southern Ending the HIV Epidemic in the U.S. (EHE) jurisdictions, there is a need for innovative, culturally-relevant, and accessible interventions to promote their HIV-related health. The present hybrid type 2 implementation- effectiveness trial will evaluate THRIVE365, a multicomponent HIV intervention designed by BMSM for BMSM living with HIV in the Southern U.S. and facing intersectional stigma and multilevel barriers to HIV care. We will examine the daily and longer-term HIV-related behavioral and psychological health impacts, stigma moderating effects, and the maintenance and reach of THRIVE365 through a 6-month trial with 350 BMSM living with HIV in four Atlanta-area EHE jurisdictions.